Fast Freezing Processes in Tissues

PROJECT SUMMARY (ORIGINAL)
The goal of the research is to advance the formulation of cryopreservation protocols for biological systems
using fundamental biophysical parameters. At present, crucial gaps exist in our knowledge of the biophysical
parameters governing the states of intra- and extra-cellular water during a fast freezing process. This proposal
aims to redress this crucial gap by introducing two new and effective techniques: (a) a measurement
technique based on microscale thermoelectric sensors, engineered using microfabrication techniques
suitable for use with artificial tissues and (b) a measurement technique based on a combination of calorimetry
and low temperature microscopy suitable for use with native tissues. Specifically, the project will: (1) design
fabricate and test microscale thermoelectric sensors to measure fast freezing processes in isolated cells
(Neonatal Human Dermal fibroblasts, NHDFs) and artificial tissues (NHDFs embedded in a collagen gel
sheet) with and without Cryoprotective Agents (CPAs) and (2) develop a combination of calorimetric and low
temperature microscopy (directional solidification) methods to assess fast freezing processes in NHDFs and
native (mammalian liver) tissue sections with and without CPAs. CPA addition and removal in both tissue
(artificial and native) systems will be modeled using irreversible thermodynamic models. These integrated
methods from disparate disciplines will lead to rational design and development of freezing processes for
cryopreservation of donated tissues, an extremely scarce resource, as well as artificially engineered tissues.
The education and infrastructure development part of this NIH AREA 15 proposal includes both instructional
and research components for LSU undergraduate students.
PROJECT SUMMARY (NIGMS Supplemental Award)
The NIGMS supplemental (equipment) award requests funds to purchase a state of the art differential
scanning calorimeter (DSC 8500) to enhance the quality of the data obtained in Aim 2 of the project. The
new instrument will allow us to limit measurement errors and to assess the true contribution of cell
heterogeneity. In addition, the new instrument will controllably freeze cells to a much higher rates (~750
˚C/min) thus allowing us to fully accomplish the goals of the original proposal, i.e., to assess fast freezing
processes in tissues.

Public health relevance
PROJECT NARRATIVE (ORIGINAL) Rational design of cryopreservation protocols requires thorough knowledge of the state of water (intra- and extra-cellular) during the whole process. Unfortunately, current optical microscopy based measurement methodologies are ill-suited to measure the fast freezing processes in tissues and embedded cells; thus, limiting our ability to rationally design and predict the response of native and artificial tissues to a freezing insult. The current proposal aims to rectify this by developing two new measurement technologies (microscale thermoelectric sensors and differential scanning calorimetry), each one uniquely suited for measuring fast freezing processes in artificial and native tissue sections. PROJECT NARRATIVE (NIGMS Supplemental Award) The requested equipment (DSC 8500) is significantly more advanced (faster cooling and heating rates, higher accuracy and precision, and an ability to measure higher thermal energy transitions) than the machine (DSC Diamond) that is currently available to the PI.